Conformance with the Manufactured Food Regulatory Program Standards (MFRPS)

Project Summary/Abstract Project Title: Conformance with the Manufactured Food Regulatory Program Standards (MFRPS) Project Description: To enhance and continue the current Nebraska Department of Agriculture (NDA) Food Safety and Consumer Protection (FSCP) MFRPS program which began in 2012. NDA FSCP’s MFRPS program aims to coordinate with all states and FDA in building a nationally integrated food safety system by achieving and maintain complete conformance with the MFRPS. This is an important accomplishment in helping with the prevention of food-borne illness in Nebraska.

Public health relevance
Project Narrative: Project Title: Conformance with the Manufactured Food Regulatory Program Standards (MFRPS) Although the United States has one of the safest food supplies in the world, the public health burden of foodborne disease in the nation is substantial. CDC estimates that each year roughly 1 in 6 Americans (or 48 million people) gets sick, 128,000 are hospitalized, and 3,000 die of foodborne diseases. New challenges continue to arise, including the globalization of the food supply and the emergence of new pathogens in foods. Nebraska Department of Agriculture (NDA) Food Safety and Consumer Protection (FSCP) MFRPS focuses on prevention. The aim is to address risks throughout a product’s life cycle, from the time a food is produced to the time it is distributed. We join FDA in its effort to ensure preventive approaches are effective. NDA FSCP’s MFRPS program is working with the focus on three core elements: Prevention, intervention and corrective action, when a response in indicated.